Cincinnati Cooperative Center of Excellence in Hematology

SUMMARY/Abstract:
The long-term goal of the Cincinnati Cooperative Center of Excellence in Hematology (CCCEH) is to
understand and correct, at the molecular level, hematological diseases of various lineages. To attain this goal,
we must understand basic biological processes that affect behaviors of hematopoietic stem cells and their
various differentiated progenies in vitro and in vivo. We envision this long-term goal will be best accomplished
by interdisciplinary and collaborative approaches using state-of-the-art methods, along with timely and rational
use of translational studies into the preclinical and clinical settings. Cincinnati Children's Hospital Medical
Center (CCHMC) has developed a rich and stimulating intellectual environment that brings together
outstanding expertise and basic research in stem cell biology, virus vector technology, immunohematologic cell
biology, genomics and genetics, and hematopoiesis; in addition, the CCCEH has world-class expertise in
translational and clinical research in hematology, immunology and hematopoietic stem cell transplantation.
This focus has been greatly strengthened by the recruitment of over 30 faculty members in these areas of
hematology research over the last 15 years at CCHMC, and the inclusion of over 15 external hematology
researchers around US. Basic research is linked with Cincinnati NIH-funded Clinical and Translational Science
Award (CTSA), which has facilitated interdisciplinary interactions and developed an infrastructure that supports
state-of-the-art clinical trials in cell and gene therapy. Here we seek to solidify the exciting and systemic growth
of research in hematology at CCHMC to support a national center of excellence, using the shared services and
administrative structure of the center grant mechanism. The CCCEH Administrative Core supports an
exceptional array of research cores, which function together to support innovative basic and translational
research both locally and nationally, in non-malignant hematology. Our three proposed research cores include
(1) Xenotransplant and Genome Editing Core, which maintains specialized mouse strains and provides mouse
transplant and transgenic services; (2) Single Cell Characterization and Procurement Core that includes state-
of-the-art imaging as well as single cell capture and gene expression capabilities; and (3) Gene Delivery Core
that covers services such as ex vivo manipulation of blood cells by lentivirus and retrovirus transduction and
shRNA/sgRNA screening. Finally, this center seeks support for an innovative Enrichment Program that fosters
a collaborative and educational environment in the center and for outreach to the broad hematology research
community around US.

Public health relevance
RELEVANCE: CCHMC provides an exceptional environment in which to study the molecular mechanisms of various aspects of hematopoiesis and to pursue innovative basic and translational research and therapies for a wide variety of non-malignant blood diseases. The Cincinnati Cooperative Center of Excellence in Hematology (CCCEH) will provide an essential organizational platform that allows coordination in basic and translational hematology research areas and will facilitate NIH funded and new studies by established and new investigators of experimental hematology around US.